The Influence of Structural Racism on Incidence of Alzheimer's Disease and Related Dementias (ADRD) in Black women

ABSTRACT
Alzheimer’s Disease and related dementias (ADRD) disproportionately affect Black Americans compared to
White Americans. Structural racism – the totality of ways by which society fosters racial discrimination and
White supremacy through mutually reinforcing, inequitable systems in housing, education, employment, health
care, criminal justice and other domains – may drive the constellation of social risk factors and comorbidities
that increase the risk of ADRD. The mechanisms and pathways by which structural racism contributes to
ADRD in Black Americans are as yet largely unexplored. We propose to assess the influence of structural
racism on incidence of ADRD in a high-risk group of Americans, Black women. Our study will be based on
participants and data from a 26-year follow-up study of 59,000 Black women from across the U.S., the Black
Women’s Health Study (BWHS). We will develop a measure of structural racism that is more comprehensive
than most currently in use and test characteristics of this measure against those of several published
measures, at the county and state level. Our new measure will use data on unemployment, poverty, level of
education, and incarceration; the data needed for its development will be obtained by linking participants’
geocoded addresses from 1995-2021 to appropriate public data sources. We will identify incident cases of
ADRD through an already developed and tested method of linkage of BWHS participants aged 65 and older to
Medicare data for the years 2008-2022; this will yield an estimated 1,500 incident cases of ADRD in 15,000 to
16,000 BWHS participants. Since enrollment in the BWHS in 1995, the participants have provided information
on a large number of health and other factors, which include potential risk factors (e.g., hypertension, diabetes,
low level of education) and protective factors (e.g., exercise, social support) for ADRD. The study has collected
information at three different times on perceived experiences of interpersonal racism, and these reported
experiences have been associated with increased risk of adverse health outcomes (e.g., weight gain) in the
BWHS, as expected. Thus, it will be possible to assess the effects of structural racism alone on incidence of
ADRD as well as the combined effects of structural and interpersonal racism. We will also study moderation or
mediation of effects by a large number of other factors on the association of structural racism with incidence of
ADRD. Since data have been collected over a period of 26 years in geographic areas across the U.S., it will be
possible to assess effects of structural racism on ADRD incidence over time and place at the county and state
level. Thus, the proposed study will provide new and important information on structural racism and ADRD in
Black women.

Public health relevance
Project Narrative Structural racism– the totality of ways by which society fosters racial discrimination through mutually reinforcing inequitable systems in housing, education, employment, health care, criminal justice and other domains-- affects minority groups in the U.S. disproportionately, including Black women. The present proposal will assess whether and how various forms of structural racism influence the incidence of Alzheimer’s Disease and Related Dementias in Black women.